Role of Serum Amyloid A in the Pathogenesis of Stroke

Serum amyloid A (SAA) proteins are critical to the regulation of inflammation in systemic as well as neurological
diseases. Studies have shown that during an acute phase response (APR), SAA levels increase 1000-fold and
can stimulate the inflammasome, trigger the recruitment of immune cells to inflammatory sites, and elicit the
induction of enzymes that degrade extracellular matrix. SAA levels are significantly elevated following
stroke/cerebral ischemia linking systemic inflammation and neurological disorders. Our long-term goal is to
dissect the mechanisms regulating SAA function, particularly the contribution to stroke related damage would
have a major impact on the clinical management of stroke by providing new biomarkers that will predict poor
outcome and death as well as strategies for intervention. Recent studies from our laboratory have provided
information for the role of SAA proteins in stroke progression: 1) SAA levels are increased in mice and humans
following stroke; 2) in mice and humans, SAA is present in the brain following stroke in regions with inflammation,
microglial activity, and neuronal cell loss; and 3) SAA deficient mice have reduced infarct volumes and
inflammation. We have shown that SAA mediated by RAGE induces NLRP3 and elaborates IL-1 in microglial
cells, indicating activation of the inflammasome. Recent studies have demonstrated that activation of the
inflammasome is a critical event in stroke progression in mice. The central hypothesis is that SAA activates the
NLRP3 inflammasome and amplifying the local inflammatory responses that enhance neuronal cell death and
stroke progression. Our specific aims will test the following hypotheses: Aim 1: Investigate the role of NLRP3
inflammasome in SAA’s ability to exacerbate stroke in mice. Aim 1a. Using mice deficient in SAA, RAGE and
various inflammasome components (cathepsin B, NLRP3, and IL-1), we will determine whether SAA-mediated
stroke outcomes are dependent on the NLRP3 inflammasome. We will also investigate whether small-molecule
anionic sulphonates, a treatment that blocks SAA deposition in tissue, is effective in reducing infarct volumes in
mice. Aim 1b. Using microglial cell cultures, we will determine the impact of SAA on RAGE mediated pathologies
(ROS generation, etc.) as well as the influence of SAA-HDL on SAA-mediated NLRP3 activation. Aim 2: To test
the hypothesis that systemic SAA exacerbates the progression of neuronal cell death and inflammation in stroke.
Aim 2a. Using SAA deficient mice, we will determine the impact on stroke infarct volume and outcomes. In
addition, using viral vectors to express SAA as well as an inducible transgene will allow us to determine the role
of SAA with specific expression of SAA. The impact of SAA on inflammation, neuronal cell death, matrix
remodeling, etc. will be determined. Aim 2b. We will investigate the role of SAA and the inflammasome in
human stroke, the relationship between plasma SAA, IL-1 and the impact on stroke outcomes. This contribution
is significant since it will establish that targeting of SAA by therapies have the potential to regulate inflammatory
activity through cellular mechanisms.

Public health relevance
Serum amyloid A (SAA) proteins are critical to the regulation of inflammation in systemic as well as neurological diseases. Studies have shown that during an acute phase response (APR), SAA levels increase 1000-fold and can stimulate the inflammasome, trigger the recruitment of immune cells to inflammatory sites, and elicit the induction of enzymes that degrade extracellular matrix. SAA levels are significantly elevated following stroke/cerebral ischemia linking systemic inflammation and neurological disorders.